The effect of gestational age at delivery on lactation outcomes in pump-dependent mothers of critically ill infants

Research Abstract
Mother own milk (MOM) provides personalized risk reduction for neonatal intensive care unit (NICU) infants,
but little is known about insufficient MOM in 84% of NICU mothers with non-very low birthweight infants,
leaving a major research gap that disproportionately impacts Black NICU mother-infant dyads. Insufficient
MOM volume has its origins in late pregnancy and postpartum days 1-14. The goal of this research is to
determine the effect of GA on lactation outcomes among pump-dependent mothers of critically ill infants
admitted to the NICU. A major lack of knowledge exists about the effect of mammary gland maturation on
MOM volume, secretory activation (SA), and if/how it is mediated by MOM removal (e.g., breast pump use)
during the critical window (postpartum days 1-14) of transition from secretory differentiation (epithelial cell
preparation) to SA (onset of copious MOM volume) and autocrine control of lactation (permanence of SA) to
ensure continued production of adequate MOM volume. To fill this gap, this revised mentored patient-oriented
research career development award (K23) proposed study will follow 188 racially and economically diverse
mothers of infants admitted to the NICU for postpartum days 1-14 and assigned to 1 of 4 groups based on the
infant's GA at delivery. Aim 1 will compare measures of MOM volume between the GA groups over postpartum
days 1-14. Aim 2 will compare measures of onset and permanence of SA using MOM biomarkers between the
GA groups. Aim 3 is exploratory to gain evidence to characterize the relationship between biomarkers and
MOM volume for the 4 GA groups. Understanding of these mechanisms and the impact of GA is critical to
translate findings into early identification and personalized interventions for this vulnerable population. To this
end, I have assembled an interdisciplinary team of senior scientists with complementary expertise in nutritional
support for critically ill infants, clinical and translational research, biostatistics, and lactation biology who will
provide mentorship to achieve the proposed training goals and facilitate my transition to an independent
research career. Essential primary training goals include: 1) Advance understanding of the biology of lactation,
maternal, and infant factors; 2) Develop and apply knowledge of the application of clinical and experimental
designs, data acquisition, data analysis, and interpretation of findings; and 3) Develop leadership, research
management, academic faculty, and grant writing skills essential for a productive research faculty member.
University of Florida (UF), Shands Children's Hospital, and UF Diary Science are ideal environments to provide
unparalleled resources to support and extend the PI's emerging translational clinical research to become a
productive faculty member and independent researcher in patient-oriented research. The revised research plan
is directly responsive to the reviewer comments and to the National Institute of Nursing Research's priorities
focused on research using multilevel approaches bridging biology to society reducing risk, improving health,
and advancing health equity, as well as aligns with NIH initiatives to prioritize human milk research.

Public health relevance
Narrative Our goal is to determine the effect gestational age at delivery has on lactation outcomes using state of the science biologic measures including mother's own milk (MOM) volume, secretory activation, and biomarkers (sodium, citrate, lactose, protein) in pump-dependent mothers of preterm and critically ill infants. Results of this prospective cohort study targeting the biology and physiology of insufficient MOM among NICU mothers are expected to move science towards filling the gap in understanding these mechanisms with gestational age as a nonmodifiable factor that may influence MOM volume and secretory activation in NICU mothers to: 1) identify and prioritize evidence based lactation care to increase lactation success in mothers of all gestational aged infants, and 2) gain new knowledge on biomarkers that may hold promise as objective outcome measures and point-of-care testing to identify and proactively manage mothers at risk for delayed and/or impaired secretory activation and compromised lactation, thus improving infant health outcomes and health equity.